Mechanisms of DNA helicases and their regulation

PROJECT SUMMARY / ABSTRACT
“Mechanisms of DNA helicases and their regulation”
Helicases are a ubiquitous and diverse group of molecular machines that separate the strands of nucleic acids.
They are essential actors in many genome maintenance processes in all domains of life, including some viruses.
As a result, helicases are biomedically important proteins, and their pathologies are associated with a number
of human diseases and cancer. Since uncontrolled unwinding is detrimental to genomic integrity, helicase activity
must be tightly regulated in the cell. Furthermore, since many helicases are able to play multiple, distinct roles
in a variety of cellular pathways, they must be activated only in the correct contexts. How these different functions
are defined and regulated remains poorly understood.
In this project, we will investigate the molecular mechanisms by which DNA helicases are regulated. Our
studies will focus on the model non-hexameric helicases UvrD, Rep, and XPD, which are critical components of
the cellular response to DNA damage in prokaryotes, eukaryotes, and archaea and also serve as prototypical
members of the two largest structural superfamilies of helicases. Insights gained on their mechanisms are
expected to extend to a number of structurally and functionally homologous systems.
Prior work by us and others has shown that these types of helicases have auxiliary domains and/or make
secondary contacts with DNA that play regulatory—often, auto-inhibitory—roles. Protein partners to helicases
have thus been proposed to activate helicase activity by controlling these mechanisms, thus defining helicase
roles in the cell. To gain insights into these mechanisms, our studies will focus on two main research goals:
understanding how interactions with DNA and non-canonical DNA structures control helicase activity (Goal 1),
and quantifying how encounters with accessory proteins—both protein partners that recruit and activate
helicases and proteins that compete for the same DNA substrates—regulate helicases (Goal 2).
Our approach for achieving these research goals will integrate advanced single-molecule biophysical
techniques—optical tweezers combined with fluorescence microscopy—together with traditional biochemistry
and computational biophysics methods. These approaches leverage our group's expertise and that of the
assembled collaborators, and have been successfully applied by us in our high-resolution measurements of
helicase unwinding and conformational dynamics, their modulation by interactions with accessory proteins, and
their connection to atomic-level structural models of helicases,. Beyond providing insights on helicase
mechanism and the genome maintenance pathways in which they participate, our studies will advance new
biophysical methods for investigating biomolecular dynamics.

Public health relevance
PROJECT NARRATIVE Helicases are essential enzymes that unwind the strands of DNA and RNA. They are critical to maintaining the genomes of all organisms, and defective helicase function is implicated in various human disorders. The project will use advanced biophysical techniques to understand the mechanisms of helicases involved in repairing DNA damage, specifically investigating how helicase interactions with DNA and with accessory proteins regulate their functions.